Mechanisms of microenvironment mediated resistance to cancer cell surface targeted therapeutics

Project Summary: Rates of FDA approval for oncology drugs in clinical trials are low and often clinical trial
failures are driven by pre-screening of therapies in models that cannot adequately replicate patient physiology.
The tumor microenvironment (TME) is highly complex consisting of multiple cell types including stromal cells,
immune cells and vasculature. The interplay between tumor cells and neighboring cells in the TME results in
environmental changes that can support tumor growth, vascularization and metastasis and, thus, plays an
important role in prognosis and treatment efficacy (e.g. by modulating resistance). It is important for clinical
prescreening models to include the TME to assess how treatment efficacy can be impacted by this multicellular
crosstalk. For men with advanced castrate resistant prostate cancer (CRPC) that have progressed to
metastasis, the disease is invariably lethal as current therapies are not curative. 90% of these patients have
developed bone metastases but the bone microenvironment has been historically difficult to model in animal
models or traditional co-culture. Therefore, in vitro models of the bone marrow TME are urgently needed to
improve pre-screening of novel therapeutics, improve clinical trial design, outcomes and expedite much
needed treatments to the clinic. Here we propose to create a tissue chip model of the bone marrow
microenvironment for testing metastatic CRPC therapeutics. Patient-derived prostate tumor spheroids model
the solid tumor embedded in a collagen hydrogel surrounded by multiple resident bone marrow stromal cells
derived from bone marrow aspirates, immune cells and iPSC endothelial cell vasculature. Cell-surface targeted
therapies, such as IMMU-132 have great potential for treatment of metastatic cancers. IMMU-132 is an
antibody drug conjugate, with an antibody against Trop 2, a receptor expressed on tumor cells, coupled to the
drug SN-38. SN-38 is a topoisomerase inhibitor that induced apoptosis in rapidly proliferating cells. We have
access to samples and data from a Phase II trial of IMMU-132 in metastatic CRPC which will allow us to
validate our bone marrow tissue chip model. In the UG3 phase, we will optimize our bone marrow tissue chip
model and demonstrate that normal and disease chip environments replicate the in vivo physiology. We will
also validate the chip for measuring responses to cell surface targeted therapies. In the UH3, we will use
clinical trial data to build tissue chips that represent patients who respond and do not respond to IMMU-132
and validate these models. These chips will be used to determine mechanisms of TME-induced treatment
resistance and identify signatures of response for use in stratifying patients for more efficient clinical trials. The
chips can also be used to screen multiple different cell-surface targeted therapies helping direct therapy choice
in future trials. The bone marrow tissue chips can be easily adapted for any cancer type that has bone
metastases and can measure a range of cell surface targeted therapies. These chips have the potential to be a
powerful tool for improving clinical trial success rates in therapies for metastatic cancer.

Public health relevance
Project Narrative There is a critical unmet need for improved models to enable more effective clinical trial design. This proposal will test the utility of a bone marrow tissue chip to identify patients with metastatic castrate resistant prostate cancer most likely to have a response to a candidate new cell- surface targeted therapeutic agent currently in Phase II/III clinical trials.